Stringent Latent Epstein-Barr Virus (EBV) Infection Collaborates with Cellular Gene Alterations to Induce EBV+ Lymphomas

PROJECT SUMMARY/ABSTRACT
Epstein-Barr virus is an important cause of human Burkitt lymphomas (BLs), Hodgkin lymphomas (HLs) and
diffuse large B cell lymphomas (DLBCLs), particularly in AIDS patients. Although the EBV protein EBNA2 (which
mimics Notch signaling) is required for EBV-induced transformation of B cells in vitro, cells that express EBNA2
have the “type III” form of viral latency, which is highly immunogenic. Thus, most EBV-infected human
lymphomas, including BLs, HLs and DLBCLs, do not express EBNA2, even in AIDS patients. There is currently
no in vivo or in vitro model available to study how EBV infection causes lymphomas in the absence of EBNA2
expression. BLs, which are largely driven by MYC translocations, have stringent type I latency (expressing only
a single EBV protein, EBNA1) and currently the major role of EBV in BLs is thought to be prevention of MYC-
induced apoptosis by the virally-encoded microRNAs. EBV+ HLs, which have type II latency, express only three
viral proteins (EBNA1, LMP1 and LMP2A) and are thought to be driven by the LMP1 (a CD40 mimic) and LMP2A
(a BCR mimic) proteins, in conjunction with cellular mutations that activate JAK/STAT signaling and a supportive
CD4+ T cell-rich microenvironment. Here we propose to use a novel in vitro cell culture model, in combination
with a cord blood-humanized (CBH) mouse model developed by our lab, to examine whether an EBNA2-deleted
EBV mutant recently constructed by our lab (ΔEBNA2 EBV) can induce BL-like, HL-like or DLBCL-like
lymphomas in vitro or in vivo when specific oncogenic pathways known to be induced in each type of tumor are
activated, or tumors suppressor genes (TSGs) associated with these tumors are inactivated. Our promising
preliminary results already suggest that over-expressing the MYC oncogene in B cells infected with the EBNA2-
deleted EBV allows cells to form BL-like tumors with type I latency in NSG mice. In Aim 1, we will determine if
ΔEBNA2 EBV cooperates with MYC, BCL6 and/or cyclin D3 over-expression to induce BL-like and/or germinal
center (GC) type DLBCL-like lymphomas in NSG mice. In Aim 2, we will determine if ΔEBNA2 EBV cooperates
with JAK/STAT activation or inhibition of plasma cell differentiation to cause HL-like lymphomas in NSG mice.
In Aim 3, we will identify novel cellular gene mutations/alterations that cooperate with ΔEBNA2 EBV to induce
BL- and/or HL-like or DLBCL-like lymphomas in NSG mice and define the mechanism(s) for this synergy. We
hypothesize that EBNA2-deleted EBV will cooperate with cellular alterations commonly found in EBV+ BLs
and/or HLs to induce BL-like and/or HL-like lymphomas in vivo (although the cellular mutations required to induce
BL-like versus HL-like tumors will be different), and that our approach will also identify novel cellular gene
alterations that cooperate with stringent EBV latency to cause AIDS-related lymphomas in humans.

Public health relevance
PUBLIC HEALTH RELEVANCE Epstein-Barr virus (EBV) is an important cause of human lymphomas, including Hodgkin lymphomas (HLs) and Burkitt lymphomas (BLs), especially in immunosuppressed hosts such as AIDS patients. EBV-infected HLs and BLs have stringent forms of viral latency (types I and II) that cannot transform B cells in vitro, and there are no in vivo models available to study how stringent EBV infection cooperates with activation of oncogenes, or inhibition of tumor suppressor genes (TSGs) to induce BLs and HLs in humans. In this proposal, we will use cord blood-humanized (and non-humanized) mouse models and a novel cell culture system to define mechanisms by which stringent latent EBV infection collaborates with activated oncogenes, inhibited tumor suppressors, and growth signals derived from the tumor microenvironment to drive BL and HL lymphomas.